Regulation of Hypoxia Inducible Factor -1α in Alveolar Epithelial Cells in Lung Contusion

Abstract Lung contusion (LC) is a common injury sustained by victims of motor vehicular accidents and blast trauma. It is also an independent risk factor for the development of ALI, ARDS and Ventilator Associated Pneumonia. The most physiologically relevant consequence of LC is hypoxia. Recent work in our laboratory has indicated that HIF1α regulation especially in type II alveolar epithelial cells is responsible for the pathogenesis of lung injury and inflammation following LC. The current proposal includes three specific aims. Specific aim 1 includes characterization of HIF-1α in LC and how it regulates the fate of hypoxic cells. Additionally the role of HIF-2 α will be evaluated. Specific Aim 2 evaluates the role of HIF-1α and interaction with IL-1β in the pathogenesis of neutrophil aggregation and activation in LC. A study of promoter determinants of IL-1β and the role of succinate and inflammasome in activation of IL-1β is proposed. Specific aim 3 examines the role of HIF-1α in regulation of pulmonary surfactant. Detailed qualitative and quantitative analyses of the effect of HIF1α down regulation on type II AEC on surfactant will be performed. The aim includes studies of expression and regulation of Surfactant protein C secondary to HIF activity in AEC. This new and substantively different departure from the status quo for altering the acute inflammatory response and thereby the progression of LC to ALI/ARDS opens specific targets for therapy in the care of the critically ill trauma patients.

Public health relevance
Project Narrative This proposal focuses on the study of Hypoxia inducible factor (HIF)-1α in the pathogenesis of acute inflammation in lung contusion (LC). LC is an important condition that frequently occurs as a result of blunt chest trauma sustained in a motor vehicular accident. It also is one of the major reasons for fatality following an explosive blast-related trauma. Data from our laboratory indicates that regulation of HIF-1α in the alveolar epithelial cell (AEC) contributes significantly to lung injury and inflammation following LC. The major regulatory effect of this compound appears to be through IL-1β induced neutrophil aggregation and activation. The proposal studies the impact of HIF-1α on hypoxic AEC and follows the fate of these cells. Additionally we examine the impact of surfactant production as a result of HIF in the AEC. The long-term goal of our research is to explore possible molecular targets that interfere with the progression of LC into severe respiratory failure.